Elucidating the Function of the Periplasmic Domain of Shape-Determining E. coli Protein RodZ

Project Summary
The peptidoglycan (PG) cell wall surrounds most bacterial cells and is essential for their integrity. In Escherichia
coli, two multi-protein complexes synthesize this structure: the Rod system for cell elongation, and the divisome
for cell division. The incorporation of new PG must be tightly controlled by regulatory components in these
morphogenic complexes to retain cell shape and prevent osmotic lysis. The divisome and Rod system are
thought to have a common evolutionary origin and contain proteins with similar functions. RodA-PBP2 (Rod
system) and FtsW-FtsI (FtsWI) (divisome) are the essential PG synthases containing a SEDS-family PG glycan
polymerase in complex with a class B penicillin-binding protein (bPBP) that crosslinks the strands into the PG
matrix. In the divisome, PG synthesis by FtsWI is activated by FtsN through its effect on the FtsQLB complex.
FtsN is a bitopic membrane protein with a largely unstructured periplasmic domain containing a small peptide
essential for divisome activation and a folded SPOR domain with PG binding activity. The proposed experiments
will focus on elucidating the function of Rod system protein RodZ, which I hypothesize is an FtsN analog that
activates PG synthesis during cell elongation. Like FtsN, RodZ is a bitopic membrane protein with a periplasmic
domain predicted to consist of an unstructured region capped with a folded domain at its C-terminal end (CFD
domain). A search for remote homologs of the CFD revealed that it shares features with domains that have
glycan binding activity. It therefore may bind PG like the SPOR domain of FtsN. We will test PG binding using
co-sedimentation assays and/or fluorescence imaging of purified cell walls mixed with labeled CFD. We will also
identify the predicted PG-synthesis activation domain of RodZ. A mutant encoding a hyperactive FtsL division
protein, FtsL(E88K), fails to grow at high temperatures and conditions conferring osmotic stress. This phenotype
can be rescued by hyperactivating the Rod system to counteract the lethal divisome hyperactivity. We have
found that overproduction of RodZ lacking the CFD suppresses the lethality of FtsL(E88K), suggesting that
RodZ activates the Rod system and that the CFD may regulate this activity. We will use this phenotype combined
with further truncation and mutational analysis to identify the minimal activation domain within RodZ and
determine if, like FtsN, it corresponds to a peptide in the unstructured periplasmic region. Inactivation of the PG
binding domain of FtsN is synthetically lethal with mutants defective in other aspects of cell wall biogenesis and
cell division, revealing the importance of this domain in divisome function. We will therefore use transposon
sequencing (Tn-Seq) to identify mutants synthetically lethal with deletion of the CFD or the entire periplasmic
domain of RodZ. Such mutations will help define conditions where this domain is essential, providing additional
clues to determine its physiological function. Overall, the results from these experiments will elucidate important
aspects of RodZ function and its role in Rod system function. The insights gained will also have the potential to
enable efforts for targeting this PG synthesis system for antibiotic development.

Public health relevance
Project Narrative New antibiotics are urgently needed as pathogens become increasingly drug-resistant, and an attractive set of targets are the bacterial machines involved in cell wall growth. In Escherichia coli, there are two major cell wall synthesizing complexes: the Rod system involved in cell elongation, and the divisome responsible for cell division. My project will investigate the function of the RodZ protein that is important for the activity of the rod system, and the insights gained have the potential to identify new vulnerabilities in bacterial surface growth to target for antibiotic development.